Genetic screens in zebrafish to identify gene-ethanol interactions

Project Summary/Abstract
Ethanol is the most common teratogen and the leading cause of mental retardation. Fetal alcohol exposure
can cause numerous birth defects, most commonly effecting the nervous system. Fetal Alcohol Spectrum
Disorder describes the full range of potential ethanol-induced birth defects and has been estimated to have a
prevalence of 10 in 1000 births. The timing and concentration of fetal alcohol exposure are important
determinants of FASD phenotypes. There also appears to be genetic susceptibility to FASD, yet we know little
about the nature of these susceptibility loci and the mechanisms by which they modify the teratogenicity of
ethanol. The zebrafish embryo is particularly useful to identify and characterize loci that may underlie the
neural defects associated with FASD. In Aim 1, we characterize the effect of ROS on ethanol teratogenesis. In
Aim 2, we determine how mTORC1 signaling, downstream of ROS, modulates ethanol teratogenesis. In Aim 3,
we characterize risk and resilience factors modulating ethanol teratogenicity. Because of the conservation of
gene function between zebrafish and humans, the results from our studies will provide key insights into the
genetic loci that interact with ethanol to cause FASD.

Public health relevance
Project Narrative Alcohol is the leading cause of preventable birth defects. Along with ethanol dosage and timing, there are genetic underpinnings to alcohol-induced birth defects. Despite this fact, much remains to be learned about the genetic predispositions to ethanol-induced birth defects. Our studies will provide important insights into the mechanisms of gene-alcohol interactions. Due to the high conservation of gene function between zebrafish and human, the results we obtain will translate to human disease: providing candidate loci for association studies, risk factors for genetic counseling and potential therapies.